Selective antimicrobial peptides from milk for bacterial vaginosis

Project Abstract
Several currently administered antibiotics raise two main concerns: resistance and non-selectivity. The
rapid rate of emerging multi-drug resistance poses a global health threat and dramatically increases
economic burden. With traditional antibiotics being largely non-selective, there are serious side effects
due to the natural host microbiome being modified, and thus a loss in homeostasis. The strong need
for innovative, potent, naturally occurring and specifically selective therapeutics have prompted us to
explore for such bioactive molecules in milk. The result of 200 million years of evolutionary pressure,
mammalian lactation guides the development of the infant and provides protection from a wide-variety
of infections. Upon fractionating thousands of naturally occurring peptides from human milk, and
discovering their antibacterial activity, we have focused on the function and mechanism of action of
novel antimicrobial peptides from human milk. One such peptide, HBCA2, an internal 12-mer
sequence of human b-casein rapidly eliminates the viability of gram-positive and gram-negative
bacteria, including but not limited to Category 1 priority pathogens. We have made the key observation
that Gardnerella vaginalis, a major bacterial vaginosis (BV)-associated pathogen, is susceptible to
HBCA2, whereas the viability of key lactobacilli linked to a healthy vaginal microbiome remains
unaltered. BV remains an unmet need, with few treatment options and high rates of recurrence
resulting in several public health concerns for women of reproductive age. It is associated with
outcomes including to not limited to pre-term labor, STI and HIV transmissions, and other reproductive
challenges. We propose HBCA2, a milk-borne, antimicrobial peptide, with its unique selectivity feature
of inertness towards commensal bacteria, as a lead candidate molecule in topical applications for the
treatment of BV—a therapy that could in turn reduce the burden of BV outcomes.
In this phase I SBIR grant, we will evaluate a larger range of G. vaginalis strains other bacterial
vaginosis associated bacteria as well as a larger number of vaginal and probiotic lactobacilli for their
response to HBCA2 and variants of HBCA2 synthesized to enhance efficacy. Additionally, we will
determine the HBCA2 mechanism of action, examine its efficacy and/or synergy to traditional
antimicrobials, characterize resistance mutations (if any), analyze the direct effect of HBCA2 on
mammalian host cells and determine the impact of function on infection and inflammation in pre-
clinical infection models of the female reproductive tract. This work will aid the preparation for Phase II,
where we will test HBCA2 in in vivo efficacy and early safety PK studies, and determine cervicovaginal
tissue impact and immune response. Ultimately, this proposal will allow us to further characterize
HBCA2 alone or in combination with additional such peptides as potent antibacterial therapeutic,
derived from milk, which can be employed for treatment of recurrent BV via topical applications.

Public health relevance
Project Narrative Bacterial vaginosis, a common recurrent infection in women of reproductive age, is associated with vaginal dysbiosis, inflammation, pelvic inflammatory disease, increased occurrence of UTI, and severe consequences that include spontaneous abortions, premature births, HIV and STD transmissions and reproductive loss in acute cases. We have discovered a novel antibacterial peptide HBCA2 and from human milk that is active against Gardnerella vaginalis, a major bacterial vaginosis (BV) associated pathogen, in addition to being potent against other BV pathogens and clinically relevant category 1 priority pathogens. Importantly HBCA2, and variants with enhanced activity are inert against a variety of commensal bacteria including lactobacilli associated with a healthy vaginal microbiome. In pursuit of a novel therapy for BV, in this proposal, we will further evaluate HBCA2 activity against BV-associated pathogens, the mechanism of its action, and impact on the infectious and inflammatory outcome in the host towards follow-up in vivo tests and subsequent development of topical applications.